DREAMS - National Research Core

The National DPR Core will draw upon the research expertise of its faculty members to advance the translation of health policy research into action to improve diabetes prevention and treatment outcomes. The National DPR Core will be dedicated to expanding core services to investigators and others outside of the DREAMS-CDTR, offering collaborations between epidemiologists, economists, and health service researchers; and facilitating linkages to community health plans, public health departments and social service agencies for diabetes researchers.